CCD BASED ANALYZER FOR MULTICHANNEL BIOSENSOR

The firefly luciferase reaction is the basis for the quantification of ATP via the emission of light which can be directly related to the amount of ATP present. ATP is a ubiquitous biochemical related to many metabolic biochemicals, i.e., sugars, amino acids, hormones, vitamins, enzymes, etc. The objective of this study is to assess the feasibility of developing a small, relatively inexpensive CCD-based analyzer for the direct detection and quantification of ATP and more importantly for the quantification of many of the biochemicals directly related to ATP utilization via phosphorylation and de-phosphorylation reactions catalyzed by a wide variety of enzymes. The instrument would be superior to a PMT based luminometer in that it could analyze an inexpensive, disposable multi--channel biosensor card simultaneously for a wide variety of clinically related analytes necessary for a correct medical diagnosis, i.e., biosensor cards for a family of tumor markers, cardiac damage markers, etc. A bench top prototype will be constructed and evaluated relative to well quantified luminescence standards to confirm the efficacy of a signal modeling equation. Evaluation will then be extended to a multi-channel biosensor card for ATP and in Phase II to a multi-channel, multi-parameter biosensor card. PROPOSED COMMERCIAL APPLICATIONS: A need exists for a small, low cost CCD camera based monitoring device which can quantify a variety of analytes on a single, disposable multi-- channel biosensor platform. Each biosensor platform would contain a panel of analytes which were clinically related to a proper diagnosis, i.e., tumor marker panel, cardiac damage marker panel, essential amino acid panel, errors of metabolism marker panel are examples of data profiles that could improve diagnoses.